Revealing signal transduction mechanisms through protein design

PROJECT SUMMARY
Nature has evolved dynamic proteins that act as sensors, detecting changes in the environment and producing
signals that allow the cell to adapt and respond accordingly. For this function, signaling proteins must adopt
multiple conformations, affording switch-like behavior between “on” and “off” states. The specific mechanisms
by which states are switched or maintained often remain elusive due to a lack of biochemical and structural
information. Herein, I propose that protein design and engineering offer a unique approach to deconvolute these
complex biomolecular processes. Specifically, I aim to use protein design to generate minimal, tunable versions
of modular signaling subdomains and engineer them into wild-type signaling protein scaffolds. This allows for
direct assessment of thermodynamic or conformational signaling mechanisms by allowing us to measure the
effect of design changes on signaling outputs. For this proposal, bacterial histidine kinases offer a promising test
system due to 1) their highly modular scaffold that is amenable to chimera engineering and 2) the coiled-coil
core through which signal transduction is propagated, as coiled-coils are highly designable. In my preliminary
efforts, I have demonstrated for the first time that a histidine kinase can be re-wired with a de novo designed
sensor domain, allowing signal transduction to be initiated from a de novo part. The proposed research expands
upon this by applying protein sequence design to vary sensor domain stability, enabling insight into how sensor
stability (and thus, the thermodynamic gap between sensor domain “off” and “on” states) affects signaling output
(Aim 1). Moving down the histidine kinase scaffold, I then propose to use hyperstable de novo designed helical
bundles to drive the geometry (conformation) of the catalytic domain (Aim 2). By systematically varying the
geometry of the de novo bundle, I can force the kinase domain to adopt a related geometry. Then, by measuring
kinase activity of the de novo/kinase chimeras, I aim to identify geometric parameters at which the kinase domain
switches activity states. Finally, I propose to apply multi-state design to generate de novo linker domains that
can adopt multiple conformations (Aim 3). Engineering of de novo/natural chimeras and experimental
characterization of multi-state designed candidates will shed light on the sequence diversity that enables
accommodation of multiple conformations. Together, these efforts will provide significant mechanistic insight into
how histidine kinases undergo signal transduction while pushing the boundaries of function-guided protein
design.

Public health relevance
PROJECT NARRATIVE Signaling proteins like bacterial histidine kinases act as switches, sensing environmental stimuli and initiating a cellular response through a series of conformational changes and enzymatic steps. For these predominant receptors, we still lack significant understanding of how signals are propagated through the protein scaffold to induce switch-like behavior. By design signaling components from scratch and engineering them into signaling proteins, we can interrogate signaling mechanisms from first principles, bringing us closer to a molecular level understanding how nature has evolved dynamic yet specific signaling pathways.